Mechanisms of T cell persistence during chronic autoimmunity

PROJECT SUMMARY/ABSTRACT
Chronic stimulation depletes memory T cell potential and leads to exhaustion. However, self-reactive
autoimmune T cell responses persist and maintain function during chronic autoimmunity. The mechanisms
behind persistence of autoimmune T cells, including resistance to regulatory mechanisms such as deletion and
exhaustion, are not fully resolved and present a critical problem to our understanding and treatment of chronic
autoimmunity. Importantly, increases in T cell exhaustion markers are correlated with autoimmune remission
and positive responses to anti-CD3 therapy in type 1 diabetes (T1D), suggesting exhaustion to be an important
regulatory mechanism in autoimmunity. Our intriguing new data show that a continuous influx of T cells from the
periphery is necessary to maintain autoimmune T cell numbers in the pancreatic tissue during autoimmune
diabetes, suggesting limitations in the ability of T cells to persist and self-renew at the tissue site. We have
identified distinct CD4 T cell beta cell antigen populations infiltrating pancreatic islets in NOD mice. These
populations are distinguished based on TCR affinity, level of stemness, differentiation, and effector function. Low
affinity T cells are generally associated with a less differentiated phenotype, and preferentially form memory T
cells. Low affinity T cells could be a critical reservoir for autoimmune T cell persistence. Whether low affinity T
cells are differentially susceptible to regulatory mechanisms in autoimmunity is unknown. In this proposal we will
interrogate autoimmune T cell capacity for stemness vs. exhaustion in the context of TCR affinity for self-antigen.
We will assess the contribution of resident vs recruited cells to the tissue-infiltrating pathogenic population. We
will determine whether high and low affinity T cells depend on the same mechanisms for survival and persistence
during chronic stimulation. In combination, the Aims address the over-arching hypothesis that TCR affinity
determines T cell persistence and avoidance of tolerance to chronic stimulation by pancreatic antigen.

Public health relevance
NARRATIVE Type 1 diabetes (T1D) is a disease characterized by T cell mediated beta cell destruction. The mechanisms behind long-term functional persistence of autoimmune T cells under conditions of chronic inflammation and continuous immune activation, which should curtail immune responses, are not well understood. We will determine the role of resident and recruited CD4 T cells in maintaining tissue autoimmunity, and mechanisms behind the persistence of high and low affinity autoimmune T cells.